Comprehensive Characterization of LVV Integration and Impact on Host Cell Biology using Novel Genomic Technologies

PROJECT SUMMARY
Lentiviral vectors (LVVs) are an effective gene therapy agent due to their ability to integrate into host DNA,
providing stable expression of transgenes. LVVs have been under clinical development as a gene delivery
system to treat diseases, including blood cancers, through the generation of chimeric antigen receptor (CAR) T-
cells. The first two CAR T-cell therapies were approved for clinical use in the treatment of lymphoma or acute
lymphoblastic leukemia in 2017, and since then four more CAR T-cell therapies have been approved by the Food
and Drug Administration (FDA) for clinical use. Despite the success of these agents, on November 28, 2023, it
was announced that all clinically approved CAR T-cell therapies were under FDA investigation due to the
emergence of cellular transformation in patients receiving LVV-derived CAR T-cells, leading to cancers, and
resulting in hospitalization or death. While much work has been done to define LVV integration profiles, such as
the identification of preferential integration into intronic genomic elements, it is still thought to be a mostly random
process. For example, LVV integration has been seen in promoters, transcription start sites, exons, and
untranslated regions, resulting in differential gene expression and alternative splicing patterns when compared
to untransduced controls. Standard methods for characterizing integration profiles, such as ligation-mediated
PCR (LM-PCR) remain constrained by short read lengths and only identify the integration sites but provide no
information regarding the proviral integrity. Short-read sequencing is limiting in situations of integration into low
complexity or repeat-rich genomic areas that cannot be efficiently mapped with these data. Additionally, LM-
PCR and other common methods require priming from long-terminal repeat regions; however, integrated
lentiviral genomes contain large deletions including, in some cases, missing LTRs that would not be captured by
current methods and may result in incomplete transgene expression from that event. To address this unmet
need, we developed a novel method, single-molecule, real-time capture (SMRTcap) that leverages long reads
to resolve integrated lentiviral genomes. We hypothesize that current methods for resolving LVV integration are
incomplete, thereby limiting our ability to comprehensively characterize LVV integration sites, proviral integrity,
and their impact on host cell biology. Using SMRTcap we will resolve LVV integrations in experimentally-
generated, primary CAR T-cells, providing a complete view of integration sites, clonal expansion, and presence
of intact transgenes. Using single-cell (sc-) isoform sequencing (IsoSeq) and sc-RNA seq on these same CAR
T-cells, we will evaluate the influence of LVV integration on host gene expression, splicing, and isoform usage.
These data will provide a comprehensive view of LVV integration into primary T cells and the impact of this event
on the host genome and host cell biology. These new insights are expected to contribute to vector safety profiling
and provide critical understanding regarding LVV-related transformations in LVV-treated individuals.

Public health relevance
PROJECT NARRATIVE Lentiviral vectors (LVVs) are Food and Drug Administration (FDA) approved for clinical use as gene delivery systems and therapeutics; however, on November 28, 2023, it was announced that all clinically approved LVV- transduced chimeric antigen receptor (CAR) T-cell therapies are under FDA investigation due to oncogenic development resulting in hospitalization or death. Current methods used for characterizing LVV integration remain limited and cannot resolve events in highly repetitive genomic regions or provide information regarding transgene intactness, making it likely that integration events are not fully described. We aim to use a novel long- read enrichment method, SMRTcap, to comprehensively characterize LVV integration profiles and transgene integrity in experimental CAR T-cells, while also evaluating the impact of these events on host gene regulation and splicing.